DEVELOPMENTAL BIOLOGY/TOXICOLOGY OF ESTROGENIC ENVIRONMENTAL CHEMICALS

Studies have continued to determine the molecular and cellular targets of estrogenic chemicals and establish the mechanisms by which interactions of estrogens with developing genital tract target cells result in permanently altered differentiation, including dysmorphology and neoplasia. In the period covered by the report, the developmentally estrogenized mouse model was used effectively to suggest an etiology for paraovarian cysts in similarly exposed women. Tissue recombination experiments established the uterine epithelium as a site for estrogen-induced differentiation defects even with a normal stroma. Moreover, the ontogency of the estrogen receptor (ER) was studied in the epithelial and stromal cells of the mouse uterus using monoclonal antibodies to the ER. A new technique for the determination of catechol estrogens using high performance liquid chromatography with electrochemical detection was developed and used to study the relative formation of catechol estrogens in liver and uterine microsomes of the mouse. In the absence of phenol red in the media, proliferative and differentiative (secretory) responses induced by estrogen could be documented in organ cultures of the mouse uterus. Control of proliferation in uterine epithelial cells grown in serum-free media was further studied and found to involve prostaglandin E1 or E2, as well as epidermal growth factor (EGF) and insulin.